A biodegradable barrier preventing anastomotic leaks after esophagectomy

Project Summary/Abstract
This SBIR Phase I application will demonstrate feasibility of LeakGuard by: 1) assessing the mechanical and
degradation properties of LeakGuard in esophageal-like conditions and 2) demonstrating LeakGuard’s ability to
protect from anastomotic leakage after esophageal resection in the porcine model. Esophageal cancer affects
over 50,000 Americans each year. The gold-standard treatment is esophageal resection, but up to 22% of
patients develop a complication called anastomotic leakage (AL), resulting in high morbidity and mortality.
Current treatments, such as stents and endoscopic vacuum therapy, do not prevent AL and still often result in
high patient morbidity and mortality, as well as extended time spent in the hospital. Existing preventative
solutions, such as omentoplasty, are surgical based and cannot be performed on every patient and have the
potential to result in very serious complications. Therefore, an unmet need exists for an effective method to
prevent AL that can be used on any patient, reducing the morbidity and mortality of esophagectomy.
SafeGuard Surgical has developed LeakGuard, a biodegradable barrier device that is prophylactically placed
within the esophageal lumen during esophagectomy. It covers and protects the esophagogastric anastomotic
site enabling esophageal healing, while concurrently preventing anastomotic leakage. The biodegradability of
LeakGuard allows for it to be administered during the esophagectomy, eliminating the need for a second surgery.
To determine the feasibility of the device, the mechanical and degradation proprieties of LeakGuard will be
assessed at pH within the esophageal lumen (4.0 and 7.0). The tensile strength, burst pressure, and fluid
permeability will be determined. The ability of the LeakGuard to protect from AL in vivo will be evaluated in a pig
model. Pigs will undergo an esophagectomy, and a simulated leak will be created and LeakGuard administered.
Pigs will be sacrificed at 7 days, 14 days, and 28 days to evaluate healing and the degree of leak protection.
Successful completion of this project will validate that LeakGuard can be used to protect from anastomotic
leakage post-esophagectomy.

Public health relevance
Project Narrative Esophageal cancer affects over 50,000 Americans each year. While esophagectomy is a gold-standard treatment for esophageal cancer, esophagectomy can result in anastomotic leakage (AL), which lead can lead to high mortality and morbidity. To solve this critical problem, SafeGuard Surgical has developed LeakGuard, a bio-degradable tube administered prophylactically that covers and protects the site of anastomosis. The feasibility of this device to protect AL will be evaluated by mechanical testing in vitro to determine the rate of degradation and strength, and by a large animal in vivo study utilizing an esophageal AL model.